Exposures, Health Impacts, and Risk for Mine Waste Contamination

PROJECT SUMMARY (Overall Core: Maier and Zhang)
The University of Arizona Superfund Research program (UA SRP) addresses the unique human health risks
encountered in the US Southwest, an area with a rich history and future of mining. The Southwest has distinct
geologic and climatic attributes that affect human health and exposures to pollution. Groundwater in Southwest
regions with rich ore deposits often has elevated arsenic levels, leading to exposure from drinking water.
Exposure also occurs by inhalation and ingestion of arsenic-associated mining dusts transported from mining
sites into the interior of homes and to exterior environments. Importantly, arsenic exposure has been linked to
the development of diabetes. Vulnerable populations residing near mining sites, including Native Americans and
Hispanic communities, exhibit increased incidence of diabetes. Our goal is to determine how chronic exposure
to mine wastes that contain arsenic contributes to the development of diabetes. We will then use this information
to help predict exposures and associated health outcomes as well as to inform public health prevention strategies
in communities that neighbor mine waste sites. To achieve this goal, we have five research projects and four
cores that will: 1) characterize how chronic mine waste arsenic exposure in mining impacted areas is linked to
diabetogenic outcomes through mediation of Nrf2 signaling; 2) determine how the gut microbiome and mining
waste mineral properties influence arsenic species transformation, bioavailability, and toxicity; 3) investigate the
influence of capping material quality on success of mine waste revegetation to enhance cap and plant
remediation technology; 4) model exposures to mining waste contaminants, accounting for socio-demographics,
to understand risk factors that drive development of diabetes; 5) mitigate the human impacts of exposure to
mining waste through effective interaction with stakeholders including regulators, the mining industry, and
affected communities; 6) serve as a global resource for human and environmental health issues associated with
metal mining; and 7) train and graduate professionals who are equipped to address complex 21st century
environmental hazardous waste problems (Aim 7). The expected outcome of this UA SRP effort is a measurable
reduction in diabetes (and other diseases) in mining communities and perhaps beyond.

Public health relevance
PROJECT NARRATIVE (Overall Core: Maier and Zhang) The University of Arizona Superfund Research Program (UA SRP) addresses the unique human health risks arising from exposure to arsenic in the US Southwest, an area with a rich history and future of mining. Here, disadvantaged mining communities experience several routes of arsenic exposure, and Native American communities in particular exhibit increased diabetes prevalence. Our goal is to build a mechanistic model of the contributions of chronic mine waste-arsenic exposure to the development of diabetes and associated metabolic disease to inform risk assessment tools that can be used to predict exposures and associated health outcomes and to inform public health prevention and interventions in communities that neighbor mine waste sites.